Application for MFRPs Funding for the Louisiana Department of Health

Project Summary
The Louisiana Department of Health is applying for funding under the
cooperative agreement with the Food and Drug Administration,
Funding Opportunity Announcement (FOA) Number RFA-FD-24-039,
Flexible Funding Model-Infrastructure Development and Maintenance
for State Manufactured Food Regulatory Programs.
The LDH meets the eligibility requirements outlined in the FOA.
Discussion
Through the Manufactured Food Regulatory Program Standards
(MFRPS) grant funds, the MSDH was able to achieve full
conformance in the ten MFRPS elements. A letter to document full
conformance was received on November 21, 2023.
Results
Through previous MFRPS funding, the LDH has investigated,
developed, written and implemented procedures for the regulatory
program for MSDH MFRPS, Standards 1-10.
The Flexible Funding Model-Infrastructure Maintenance for State
Manufactured Food Regulatory Programs grant will provide the
LDH staff the resources needed to continue maintenance and
improvements to the MFRPS, Standards 1-10.

Public health relevance
Project Narrative Funding under the Flexible Funding Model will allow the Louisiana Department of Health/Office of Public Health to continue working under full conformance with the Manufactured Food Regulatory Program Standards by building capacity in our food safety program. The focus will be on the protection of the public health in collaboration with the Food and Drug Administration and other stakeholders as part of a nationally-integrated food safety system.